Confronting the Barrier to Stable Transplantation Tolerance Posed by Memory T Cells

Project 2 Summary
Transplantation tolerance promises to facilitate long-term allograft acceptance while avoiding the need for
life-long immunosuppression and its associated problems. In the past decade, operational clinical transplantation
tolerance has been achievable through hematopoietic stem cell transplantation or weaning of conventional
immunosuppression. However, the vast majority of transplant recipients fail to achieve allograft tolerance, and a
subset of operationally tolerant transplant recipients eventually experience graft loss. High frequencies of
memory alloreactive CD4+ or CD8+ T cells have been identified as potent barriers to the successful induction of
transplantation tolerance. There continues to be an urgent need to identify new strategies for overcoming the
barrier posed by memory T cells; Project 2 proposes to address this need. We recently showed that memory T
cells resist infectious tolerance mechanisms, and cannot acquire the cell-intrinsic hypofunctional states attained
by naïve T cells. Moreover, in sensitized recipients harboring memory T cells directed to just a single donor
antigen, we reported that the larger repertoire of naïve donor-specific CD4+ Tconv also develops resistance to
co-stimulation blockade-induced tolerance. We refer to this phenomenon as “linked sensitization” and posit that
understanding the mechanism underlying this barrier to co-stimulation blockade-induced allograft tolerance is
not only relevant to recipients with heterologous memory T cells, but also can lead to the identification of new
targets that synergize with co-stimulation blockade to achieve transplantation tolerance. Aim 1 will focus on
defining the mechanism of linked sensitization. Our observations that memory T cells are resistant to being
programmed into cell-intrinsic hypofunctional states identify a gap in knowledge as to whether, and how, memory
T cells may be programmed to tolerance. To this end, we leveraged the physiologically powerful processes of
pregnancy that program T cells specific for the semi-allogeneic fetus to spontaneously accept subsequent
offspring-matched heart allografts. Remarkably, we show that pregnancy is able to program memory T cells,
generated by the rejection of fully mismatched skin grafts, to become hypofunctional and susceptible to co-
stimulation blockade-induced transplant tolerance. We will define the mechanisms by which pregnancy programs
hypofunction in CD8+ and CD4+ T cells in Aims 2 and 3, respectively. The proposed studies have direct relevance
to post-partum transplant recipients, and will likely yield a conceptual and potentially therapeutic roadmap for
programming hypofunction and susceptibility to co-stimulation blockade-induced transplant tolerance in memory
T cells. Thus, insights gained from our studies will ultimately be applicable to sensitized transplant recipients of
both sexes.

Public health relevance
Transplantation tolerance, a state of immune hyporesponsiveness to a graft following cessation of immunosuppressive therapy, can prevent complications from life-long global immunosuppression but is rarely attained in the clinic. This PPG addresses the barriers to both the induction and long-term maintenance of transplantation tolerance, and explores two potential solutions that leverages the natural ability of pregnancy to tolerize fetus-reactive T cells and harnesses the capacity of chronic antigen exposure to drive immune hypofunction.